Gut Microbiome Contributions to Human Episodic Memory and the Role of Early Life Stress

Project Summary
A rapidly growing literature in animal models suggests a brain-gut axis where microorganisms
inhabiting the host intestinal tract, the gut microbiota, impact brain functions related to both
memory function and depressive-like behaviors. In humans, poor episodic memory is linked to
the development and perpetuation of depression, but evidence linking gut microbiome
composition with memory is limited. Studies examining the relation between human microbiome
composition, memory performance and factors related to emotional disorders generally have
small sample sizes and modest results. Although many of these studies use probiotic
manipulations to improve memory or symptoms, the type of probiotic used is either derived from
research with rodent models or one that is generally available to the public. Given the lack of
concordance between stable gut microbiome profiles in rodents and humans, and the non-
specific nature of commercially available probiotics, a more effective approach might be to
identify variations in stable gut microbiota profiles in humans associated to memory function.
Decoding which features of the human gut microbiota are related to memory would enable the
development of targeted microbiome interventions. Using a large sample of healthy participants
and patients with depressive symptoms, the proposed research will identify the specific
relationship between human microbiota variability, episodic memory function and early life
stress, an established risk factor for emotional disorders. Decoding which features of the human
gut microbiota are related to memory would enable the development of more effective, targeted
microbiome interventions. Analyses under Specific Aim 1 will characterize the relationship
between variability in gut microbiome composition in humans and episodic memory
performance. Analyses under Specific Aim 2 will explore the role of early life stress in mediating
the relationship between microbiota variability and episodic memory. Identifying the specific
relationship between microbiota variability, episodic memory function and early life stress is a
critical step in the development of targeted gut microbiota interventions to enhance episodic
memory and reduce the risk of emotional disorders.

Public health relevance
Project Narrative A rapidly growing literature in animal models suggests a brain-gut axis where microorganisms inhabiting the host intestinal tract, the gut microbiota, impact brain functions related to both memory function and emotional disorders. The proposed research will identify the specific relationship between microbiota variability, episodic memory function and risk factors for emotional disorders in humans. Decoding which features of the human gut microbiota are related to memory and risk factors for emotional disorders would enable the development of more effective, targeted microbiome interventions.